Establishing Acanthamoeba as a modern model parasite for infectious disease biology and comparative metabolism by defining mitochondrial proteins and pathways

PROJECT SUMMARY / ABSTRACT
This proposal presents a five-year research and career development plan focused on establishing
Acanthamoeba castellanii—the third leading cause of infectious blindness and a cause of fatal brain
infections—as a modern model parasite for studying infectious disease biology, comparative metabolism,
and mitochondrial molecular biology, specifically by defining its mitochondrial proteins and pathways.
The candidate, Jonathan Stefely, MD, PhD, completed clinical pathology training at Massachusetts
General Hospital (MGH) and is now a postdoctoral researcher under the mentorship of Dr. Vamsi
Mootha at MGH. Dr. Mootha is a pioneer in mitochondrial biology, genetics, and biochemistry, and has
trained 80 scientists, including 29 postdoctoral scientists that now hold independent scientific leadership
positions. The proposed project builds on Dr. Stefely’s previous research experience in biochemistry,
now extending this work into unstudied areas of parasitology through an innovative and robust
collaboration with local expert parasitology advisors, facilitated by his primary mentor, Dr. Mootha.
Protozoan parasites span diverse branches of eukaryotic biology and contain strikingly diverse
mitochondria, which are a proven anti-parasite drug target. Yet, most parasite mitochondrial biochemistry
remains undefined. A central thesis of this proposal is that a systematic characterization of unique
Acanthamoeba mitochondrial biochemistry that is not conserved in humans will unlock both new biology
and new drug targets. In preliminary work with a team of collaborators at MGH, the Broad Institute, and
Boston University, Dr. Stefely completely re-annotated the nuclear genome of Acanthamoeba castellanii
and generated a high-quality draft of a new mitochondrial proteome inventory. Here, Dr. Stefely proposes
to finalize and validate this Acanthamoeba “MitoCarta” (Aim 1) and to characterize select parasite
mitochondrial proteins and pathways that were uncovered through his work, starting with an atypical
branched electron transport chain (Aim 2) and novel proteins that function on mitochondrial DNA
(mtDNA) (Aim 3). These three independent aims will build new knowledge of mitochondria, electron
transport chains, mtDNA molecular biology, and potential anti-parasite drug targets. This mentored
career development project will provide new training and expertise in parasitology, mitochondrial
physiology, anoxic biology, and molecular biology—robustly supported by an exceptional group of
mentors, advisors, collaborators, and unique resources at MGH, the Broad Institute, and Boston
University. This project will also enable Dr. Stefely’s transition to independence with a focus on using the
new Acanthamoeba genome annotation and MitoCarta to turn Acanthamoeba into a first-class model
parasite for providing fundamental insights into the biology of protozoan parasites in clinical pathology.

Public health relevance
PROJECT NARRATIVE Protozoan parasites collectively impact nearly one billion people per year globally and are spreading due to climate change, but current drug treatments for protozoan parasite infections are limited by toxicity or drug resistance. This project aims to nominate novel potential parasite drug targets by defining unique biochemical pathways and proteins in parasite mitochondria, here focusing on the pathogenic amoeba Acanthamoeba castellanii, which can cause infectious blindness in contact lens users or fatal brain infections in people with weakened immune systems. This work promises to reveal new fundamental biology and to set the stage for future biomedical translation and readiness for fighting emerging infectious protozoan parasites.